PREDIABETES BY BETA CELL FUNCTION FOR IMMUNOASSAY

Immunointervention therapy may be an effective therapy for individuals at the early preclinical stages of IDDM. The appropriate target population for such therapy is those with a high risk of eventual progression to frank IDDM. We are studying autoantibodies to new and existing antigens, autoantibody isotopes, HLA, genotypes, and peripheral blood T-Lymphocyte assays, all as potential early marker of progression.